Shared Mechanisms of Tau Toxicity Among Neurodegenerative Diseases

Project Summary
Many neurodegenerative diseases share neuropathological and clinical features. If this overlap is any indication of
shared pathogenic mechanism, therapeutic targeting of such mechanism may have the potential to alleviate a broad
spectrum of diseases. Hyperphosphorylation and aggregation of tau is a pathological hallmark of primary tauopathies
such as Frontotemporal Dementia (FTD) and Progressive Supranuclear Palsy (PSP) and secondary tauopathies that
include some of the most common neurodegenerative diseases such as Alzheimer's disease (AD), and possibly
Parkinson's disease (PD) and Huntington's disease (HD). Tau abnormality and beneficial effects of tau reduction have
also been observed in experimental models of autism, depression, epilepsy, stroke, and traumatic brain injury, even
though these models may not develop prominent intraneuronal accumulations of tau aggregates as in primary or
secondary tauopathies. Dysfunctional mitochondria is also a prominent feature of the above diseases. Whether tau
abnormality and mitochondrial dysfunction are mechanistically connected and can be targeted together to treat
common neurodegenerative diseases is a key question this project aims to address. To effectively target tau, a deeper
understanding of its normal physiological function as well as its pathogenic role in disease is needed. Previous studies
revealed extensive tau interaction with mitochondrial proteins, and studies in animal models and humans have
revealed a specific link between tau and mitochondrial complex-I (C-I) dysfunction, although the exact mechanism is
unclear. C-I is the largest multisubunit complex of the respiratory chain, containing 45 subunits in humans. Despite
the essential role of C-I in mitochondrial function and bioenergetics, partial but not complete inhibition of its specific
subunits offered beneficial effects on lifespan or age-related neurodegenerative disease across species. The
molecular mechanism underlying this phenomenon is not well understood. Our recent studies on C-I mediated reverse
electron transfer (RET) have offered some clues. Under certain thermodynamic conditions, for example when forward
electron transport (FET) is blocked while membrane potential (MMP) is still high, RET will prevail, moving electrons
from CoQH2 back to the NAD+/NADH binding site of C-I, producing a significant amount of ROS (RET-ROS) and
lowering NAD+/NADH ratio. RET is considered a major source of mitochondrial ROS production, and our recent
studies indicate that it is also a main determinant of mitochondrial and cellular NAD+/NADH ratio. In Preliminary
Studies, we find that RET is activated during aging and in age-related neurodegenerative diseases such as FTD, AD,
PD, and HD, and that genetic reduction of select C-I proteins involved in RET or pharmacological inhibition of RET is
beneficial in these conditions. The goal of this study is to use in vivo animal models and human iPSC-derived cell
culture models to investigate the mechanism of RET regulation by tau and how tau-induced RET deregulation
contributes to a broad spectrum of age-related neurodegenerative diseases including AD and AD related dementias
(AD/ADRD).

Public health relevance
Project Narrative Abnormality of tau is a common pathological feature of neurodegenerative diseases collectively known as tauopathies. There is also overwhelming evidence implicating defects in mitochondria and especially mitochondrial complex I in the pathogenesis of these diseases. This project will test a novel mechanism by which pathogenic tau and mitochondrial complex I dysfunction are connected and thus has the potential to offer new therapeutic strategies for a broad spectrum of neurodegenerative diseases, including Alzheimer's disease and Alzheimer's disease related dementias (AD/ADRD), for which there is currently no effective treatment.